Developing Research Careers in the Hearing Sciences

Project Summary/Abstract
The specific goals for the proposed T35 Pre-Doctoral Research Traineeship Program at Vanderbilt University
are to recruit high-quality students as T35 research trainees, provide a productive and meaningful traineeship,
nurture the foundation that transforms a clinical to research mindset, and facilitate progression towards a
career as an independently NIH-funded clinician-scientist. This program supports the goal of the NIH to build a
strong clinician-scientist workforce to meet biomedical, behavioral and clinical research needs. The proposed
T35 pre-doctoral traineeship program is specifically for graduate students in training for a clinical doctorate in
audiology (AuD). Scientists with a clinical background, such as audiology, are well positioned to identify key
clinically driven questions that will ultimately impact patient care and outcomes. Despite the importance of
engaging clinicians in research careers, the small number of individuals with clinical training in audiology who
are obtaining research expertise and credentials via a PhD in hearing science remains a concern. Short-term
support for three months of full-time research training is requested for five pre-doctoral (AuD) students per year
for each of the five years of the grant. Trainees will select from among twelve well-established preceptors with
active research programs in the Department of Hearing and Speech Sciences at Vanderbilt University. Each
trainee will conduct hands-on research involving all phases of a specific project in a laboratory under the
guidance of their preceptor, complete a formal T35 research course taught by the T35 preceptors, participate
in journal club discussions, complete training in responsible conduct in research, and complete additional
activities typical of a research environment. The Vanderbilt preceptors' research areas span basic and
translational research in animal and human models and address a wide range of topics including cochlear and
neural physiology, development, aging, hereditary hearing loss, spatial localization, motion perception,
directional hearing and amplification, pediatric audiology, speech recognition, cochlear implants, vestibular
function, and multisensory cortical function. Trainees will learn about the many aspects of developing,
designing, collecting and analyzing data, and reporting the results of a research study. All trainees will present
the results of their research at a national scientific meeting and develop a manuscript, in collaboration with their
preceptor, publishable in a peer-reviewed journal. Strengths of the proposed traineeship program include the
standing of the Vanderbilt AuD program in the academic community, the excellent research environment with
state-of-the-art laboratories, numerous collaborations among the preceptors, and strong institutional support.
Independent researchers with clinical backgrounds are well suited to identify and solve public health problems.
The proposed program will provide focused research training with the goal of developing a scientific mindset
that leads the trainee to a research career in hearing and/or vestibular science. This will benefit society by
ensuring a strong future for evidence-based research related to hearing health and patient care.

Public health relevance
Project Narrative The proposed short-term research traineeship program provides a pathway for pre-doctoral students in the clinical field of audiology to expand their knowledge of research and foster development of a research mindset. Completion of this research traineeship will facilitate progression towards a career in research as a clinician- scientist. Supporting an increase in the clinician-scientist workforce will benefit society by ensuring a strong future for discovery and advances in hearing health and patient care.